Washington National Primate Research Center

Washington National Primate Research Center: Abstract
Overall Component
This P51 renewal application is submitted to the NIH for funding for FY 61-65 for the Washington National
Primate Research Center infrastructure support as one of seven Primate Research Centers within the national
network of NIH-based research centers requiring infrastructure support for ongoing specialized research
requiring the NHP model. This application presents an Overall Component describing the organization of the
WaNPRC as it relates to the host institution, the University of Washington, as well as the reporting structure of
the WaNPRC to the University of Washington’s Office of Research. The Overall Component also delineates
the structure internal to Center, detailing its administrative, scientific, and animal research units. A focus is
given to the long-standing Neuroscience Unit which has recently expanded, as well as the re-organization of
the Infectious Disease and Translational Medicine Unit and the newly formed Gene Therapy and Regenerative
Medicine Scientific Unit. A recommendation of the WaNPRC’s National Scientific Advisory Board was to
consolidate its colony locations, now completed at the Arizona site, fully described within the Animal
Resources Division. The Global Programs Division has continued to extend its international collaborations
and ensure nonhuman primate availability benefitting the overall NPRC research network. Of special
significance is the scientific progress over the last funding period in multiple biomedical specialties, including
performance progress on aspects of SARS-CoV-2. The WaNPRC has undergone a transition in its reporting
structure to the UW Office of Research and a thorough analysis for strategic planning purposes for the
upcoming funding period. Supportive documentation in the form of Letters of Support are included as well as a
detailed report of the budget figures requested aligned with justifications for associated budget requests.
Governance and oversight of the WaNPRC are described as well as a narrative regarding the key
organizational changes that have recently evolved at the Center. This P51 renewal grant application
demonstrates the WaNPRC’s mission aligning its resources and funding as a primary underpinning of the
mission of the National Institutes of Health.

Public health relevance
Washington National Primate Research Center: Narrative Overall Component The Washington National Primate Center’s Mission is inherently linked to the mission of the National Institutes of Health as one of its primary resources for scientists requiring the nonhuman primate model in research for the improvement of human and animal health within the United States, and world-wide.